Administrative Core

The Administrative Core (ADMIN) is responsible for the leadership, integration and successful operations of the
COBRE in Stroke Recovery. The PD/PI and Associate Director are assisted by an Executive Committee and
Internal Advisory Committee as well as an External Advisory Board of 5 eminent scientists who provide objective
oversight, peer review, evaluation and strategic interactions to optimize the Center’s impact. The ADMIN Core
supports the effort of the Program Director (PD/PI), Mentors of 4 Phase II Junior Investigators, Director of a
competitive peer-reviewed Pilot Project Program, and a team of experienced support personnel who handle
fiscal management and reporting, scheduling, coordination of COBRE activities, evaluation activities, IT and
communication/dissemination functions. Aim 1 is to provide integrated fiscal and administrative management for
all components of the program, including coordination of meetings, management of fiscal and personnel matters,
oversight, accountability, enhanced website features, and dissemination of results. Aim 2 is to enhance the ability
of individual investigators to obtain peer-reviewed grants and establish long-term academic research careers in
stroke recovery through intensive multiple source mentoring, access to core resources, and diversified
opportunities for research support. Aim 3 is to continue our successful Pilot Project Program in stroke recovery
research. Aim 4 is to provide scientific and programmatic leadership for success and sustainability via three sub-
aims that address: a) strategic planning and implementation, b) increasing and diversifying the research portfolio,
and c) promoting the finanical independence of the center, including appropriate cost recovery/reimbursement
models for core services. Aim 5 is to continue to evolve our integrated Evaluation Program, focusing on six long-
term strategic goals developed during Phase I and implementing a full suite of metrics to guide infrastructure
development, including a dashboard of key metrics. Innovative features of the COBRE’s conceptual and
administrative structure include: a) a multidisciplinary leadership team that includes a PhD biomedical
engineer/biomechanical scientist and an MD/clinical stroke expert, coalescing resources and disciplines from
the Colleges of Health Professions and Medicine; b) our multiple source mentoring approach bringing
multidisciplinary perspectives, expertise and tools to serve the Junior Investigators’ development toward
research independence; c) technological innovations fostered by frequent interactions of experts in diverse fields
of brain biology, bioimaging and biomechanics; d) a Pilot Project Program using a novel web-based platform
developed by MUSC’s CTSA (SCTR); and e) development of a dashboard of key metrics in infographic style for
COBRE leadership to monitor progress and make program modifications as needed to strengthen the Center.